Impact of early microbial exposure on immune ontogeny

PROJECT SUMMARY / ABSTRACT:
Early life microbial exposure can permanently program the offspring’s immune system and life-long disease risk.
For example, children exposed to farm environments are less likely to develop asthma, and antibiotic use in early
life is associated with an increased risk of developing inflammatory bowel disease and diabetes. Recent studies
have also observed a correlation between cesarean section birth and diabetes, asthma and allergic disorders
later in life. However, these studies are based on epidemiological associations, and the underlying mechanisms
remain undefined. In this administrative supplement, we will leverage a unique pet-shop ‘dirty’ mouse model to
determine how the microbial environment alters the generation of immune cells from hematopoietic stem cells
(HSCs). Our preliminary data indicates that adult mice raised in a dirty environment are more resistant to infection
because they contain more ‘fast-acting’ lymphocytes made by fetal HSCs and fewer ‘slower-acting’ lymphocytes
made by adult HSCs. However, all of our studies to date have been performed with mature lymphocytes, and
we have yet to explore the impact of the microbial environment on the HSC compartment. Thus, we are seeking
funds to use a single-cell RNA-seq platform to examine how the microbial environment alters the transition from
fetal to adult hematopoiesis. Knowledge gained from these studies will provide key insights into how the early
microbial environment leads to permanent changes in immune development and later-life susceptibility to
disease.

Public health relevance
Project Narrative The goal of this study is to dissect how microbial exposure at the maternal-fetal interface sculpts immune development and functions in the offspring. These results are expected to deliver a novel paradigm for developing new preventive and therapeutic strategies against immune disorders that originate early in life.